Engineering therapeutic cellular functions using robust and highly programmable extrachromosomal genetic technologies

PROJECT SUMMARY/ABSTRACT
Current strategies to engineer human cells for cell-based therapeutics and biotechnologies rely upon the
genomic integration of transgenic payloads. Although these approaches have catalyzed transformative
medical advances, the integration of transgenic DNA permanently disrupts natural genomic sequences
and can lead to unexpected and even hazardous consequences. In addition, integrated transgenic DNA
is often unpredictably expressed and is prone to epigenetic silencing over time, especially within
primary/therapeutically useful cells. Further, the installation and validation of integrated cargoes is
inefficient and costly. These critical barriers limit the extent to which human cells can be repurposed and
engineered as cell-based therapeutics and these challenges are preventing biotechnological and clinical
innovations. Non-integrating, double-stranded DNA viruses have evolved sophisticated solutions to these
important obstacles, and they can stably persist within human cells as circularized self-contained
episomes or linear extrachromosomal elements across cellular divisions and for the lifetime of infected
hosts. These viruses accomplish this remarkable persistence by tailoring their own gene expression
patterns, synchronizing their genomic replication, and by reshaping endogenous transcriptional networks
in host cells. In this proposal, we will harness and redirect these natural abilities towards biomedically
useful outputs using clinical-grade non-integrating gene therapy vectors and cell types. Our project will
establish new ways to program and apply extrachromosomal DNA within human cells.
In Aim 1 of this proposal, we will optimize our recently developed genetically encoded extrachromosomal
modules to further refine and enable i) site-specific and tunable localization of extrachromosomal
payloads, ii) programmable episomal/extrachromosomal replication, and iii) multi-layered safety
switches; across a battery of human cell types to ensure robust utility. In Aim 2, we will deploy our
established extrachromosomal modules in four clinically proximal primary cell types using widely adopted
viral vectors for gene and cell therapies: integrase-deficient lentiviral (IDLV), high-capacity adenoviral
(HCAdV), and herpes simplex viral (HSV) vectors. In Aim 3, we will build proof-of-concept sense and
respond genetic circuits within IDLV, HCAdV, and HSV viral vectors to modulate the expression of
transgenic extrachromosomal and endogenous therapeutic payloads by combining these platforms with
synthetic CRISPR/Cas9-based transcription factors in clinically useful primary cells. Collectively, our
project will broadly empower cell engineers, synthetic biologists, and biomedical researchers with new
capabilities to tunably control the expression of therapeutic payloads from a wide array of
extrachromosomal vector systems and across a spectrum of clinical grade cell types without the hazards
and obstacles associated with genomic integration or double strand breaks.

Public health relevance
PROJECT NARRATIVE The next generation of human health improvements and medical advances will continue to be driven by the ability to use cells as therapeutics. Current strategies to utilize cell-based therapeutics have made remarkable progress but remain limited in terms of persistent efficacy and patient safety in large part because they rely upon disruption of our native genetic code. This project will enable innovative new ways to safely and effectively repurpose human cells as customizable medicines without alterations to the human genome to ultimately prevent and better treat a wide range of human ailments.